Career Enhancement Program

PROJECT SUMMARY (Career Enhancement Program)
The goal of the Career Enhancement Program (CEP) is to provide training and guidance for academic
physician-scientists, clinician-investigators, and laboratory-based scientists who wish to dedicate their career
and research efforts to leukemia translational research. To achieve this goal, the CEP will pursue the following
specific aims:
1. Recruit, train, and mentor physicians, scientists, and senior postdoctoral fellows to become
excellent leukemia investigators focused on leukemia translational research.
2. Educate awardees in all the basic principles of cancer and leukemia biology, including molecular, cellular
and systems biology, drug development, pharmacokinetic and pharmacodynamics studies, and basic
principles of biostatistics and bioinformatics.
3. Provide a firm foundation for awardees in the specific area of leukemia translational and early clinical
research.
These objectives will be achieved through strong mentorship in which awardees will be instructed in the
principles of clinical, basic, and translational leukemia research. Specific areas of education will include
scientific and clinical methods, biomedical ethics, statistical design and analysis, bioinformatics, biology,
biochemistry, genetics, epidemiology, and other areas relevant to individual projects. Mentorship will include
laboratory-based investigators, clinical-translational investigators, biostatisticians, bioinformaticians and
epidemiologists. Mentors from within the Leukemia SPORE and the other 1,500 faculty members at the MD
Anderson Cancer Center, Graduate School of Biomedical Sciences, Fox Chase Cancer Center and from the
University of Texas in Houston, will provide the expertise required for the development of strong, productive
translational research skills.
Since its inception in 2003, the CEP has funded 54 awards given to 36 recipients, including 14 women and 14
minorities, who have gained skills and expertise in designing and conducting clinical translational-based
studies in leukemia, including incorporating laboratory-based studies in clinical trials and, conversely,
transforming critical clinical observations into meaningful laboratory investigations. The majority have
continued independent academic careers in leukemia or cancer research. Thus, this program has contributed
to the career development of talented young leukemia investigators to hasten the development of effective
new therapeutic strategies against leukemia.

Public health relevance
PROJECT NARRATIVE (Career Enhancement Program) The Career Enhancement Program fosters the scientific development of investigators who intend to focus their careers on translational studies of leukemia. This is achieved by recruiting innovative entry-level scientists to enhance the SPORE’s overall translational research capability, helping these individuals develop intellectual and technical skills required to be productive investigators, and teaching these individuals basic principles of translational research.